Rod photoreceptor regeneration in a zebrafish model of Retinitis Pigmentosa.

Abstract:
A cellular hallmark of inherited retinal degenerative diseases, such as Retinitis Pigmentosa (RP), is progressive
loss of photoreceptors until the individual is completely blind. With degeneration starting at an early age, many
patients with RP become blind early on in their adulthood. Affecting 100,000 people annually in the US alone
and being the second most prominent genetic retinal degenerative disease worldwide, research is necessary in
order to identify therapies that can improve the quality of life for these patients. Unlike mammalian models,
Zebrafish (Zf) have a remarkable capacity to regenerate neurons following retinal injury or disease, making them
a suitable model organism for regenerative studies. Current studies in Zf have indicated that upon detection of
retinal insult, Mϋller glial cells (MGCs) are reprogrammed to re-enter the cell cycle, asymmetrically divide, and
produce multi-potent progenitor cells. These newly formed progenitor cells rapidly proliferate and re-differentiate
to replace lost retinal cells. Several genes, pathways, and transcriptional factors have been shown to play a role
in reprogramming MGCs, inducing progenitor cell proliferation, and differentiating these cells into functional inner
retinal neurons; however, the mechanisms by which genes work together spatially and temporally to regenerate
rods in a model with chronic retinal degeneration remain unknown. The purpose of this study is to understand
the regeneration mechanisms of rod photoreceptors in Zf and to identify the master regulatory genes crucial for
their lineage trajectory. Our preliminary analyses have identified a group of retinal progenitor cells believed to be
responsible for rod photoreceptor regeneration. Aim 1 of this proposal will assess the roles of candidate
regulatory genes and transcription factors in the differentiation of these progenitor cells into rod photoreceptors.
Aim 2 will assess the lineage trajectory of progenitor cells to form rod photoreceptors and identify when and how
the progenitor cells are formed. Upon successful completion of this project, I will have identified the set of
transcription factors needed to induce rod photoreceptor regeneration in adult Zf. The ultimate goal of this project
is to provide the targets necessary to restore vision in blind patients with retinal degenerative diseases such as
RP so that they may have an improved quality of life.

Public health relevance
Retinitis Pigmentosa (RP) is a chronic retinal degenerative disease that affects about 100,000 people in the United States annually and ultimately results with patients becoming blind early on in their adulthood. Regenerative therapies to treat this disease could reduce the incidence of blindness in RP patients as well as dramatically improve their quality of life. This project seeks to identify the gene expression networks that control the photoreceptor regeneration process so that current therapies can directly target and successfully treat patients with RP.